Admin core - NINDS INSTIUTIONAL CENTER CORE GRANTS TO SUPPORT NEUROSCIENCE RESEAR

Overview The administrative core will be responsible for overseeing the operation of the Center, including scheduling Steering Committee and Center all-hands meetings, managing training programs, and programming the lecture series. Working closely with the Steering Committee, the Administrative core will establish the Center's overall agenda, set timelines for deliverables, and monitor their progress. The Administrative Core will also lead promotional efforts and a revamped user outreach initiative. Leadership and staff The Administrative Core will be led by Mark Mintun. Dr. Mintun is the Mallinckrodt Institute of Radiology (MIR) Division Director of Research Development and interim Director of Radiological Sciences which includes the NIL and Cyclotron Facility. He is also the Director of the CCIR and of the imaging component of the Clinical and Translational Science Award (CTSA). In 2006, he was the PI of a High End Instrumentation grant to purchase a Siemens Biograph PET/CT (which is in the CCIR). Dr. Mintun, with Dr. Marcus Raichle, developed methods to image and quantitate oxygen metabolism and receptor availability in vivo (coining the term Binding Potential), and conducted pioneering work in methods to map brain function. Patricia Aldea will serve as the NCCBI's user outreach specialist. This newly created position, which is described in detail below, is being established in direct response to user feedback that additional support is required for them to optimally use the Center's resource. A software engineer will provide algorithm, application, and visualization development. This position will be funded by the Department of Radiology, as described in the letter from Dr. Jost, allowing the engineer to contribute to the Center in ways that compliment the allowable costs described in the RFA.